ANTIRETRIVIRAL THERAPY OF PROGRESSIVE MULTIFOCAL LEUKOENCEPHALOPATHY IN HIV

This study will evaluate the efficacy of adding cytosine arabinoside to standard antiretroviral therapy in treating progressive multifocal leukoencephalopathy in patients with HIV infection.